TAMOXIFEN BREAST CANCER PREVENTION TRIAL

Multi-center randomized trial to determine if tamoxifen in a daily dose of 20 mg. reduces the risk of developing breast cancer compared to placebo. Women eligible for the study include women over the age of 60 or women 35 to 59 who have an estimated risk of developing breast cancer similar to that of a 60 year old woman.